Anti-inflammatory activity of hydrogels designed to capture extracellular inflammasomes

PROJECT SUMMARY/ABSTRACT
Multiprotein complexes known as inflammasomes form in innate immune cells to trigger inflammation upon
detection of pathogens or tissue damage. Abnormal inflammasome activation leads to chronic inflammation,
which is the culprit of numerous life-threatening diseases such as cancer, diabetes, cardiovascular disorders,
and the cytokine storm in SARS-CoV-2 infection. Inflammasome assembly is controlled by protein-protein
interactions as it requires the self-association and oligomerization of multiple copies of three proteins: sensors
to detect danger signals, a protease to activate inflammatory factors, and the adaptor protein ASC to connect
sensor and protease. Inflammasome formation leads to plasma membrane rupture and concomitant cell death,
thus resulting in the release of proinflammatory cytokines and inflammasome particles to the extracellular
environment. These extracellular inflammasomes are internalized by nearby cells to perpetuate and amplify the
inflammatory response. Removing or sequestering extracellular inflammasomes will likely inhibit or reduce
inflammation. Therefore, extracellular inflammasomes are potential therapeutic targets. Our laboratory’s
extensive experience on the function and structure of the adaptor ASC, and its interactions with other
inflammasome proteins, has led us to create hydrogels designed to form specific protein-protein interactions with
inflammasomes; thus, they have the potential to broadly inhibit inflammation by effectively capturing and
removing extracellular inflammasomes. This project focuses on identifying the hydrogelation factors leading to
optimum biding of inflammasome particles in cell-free systems (Aim 1); and determining the anti-inflammatory
efficiency of the hydrogels in the presence of activated innate immune cells (Aim 2). Our experimental plan will
combine cell biology and biochemical approaches, including live/dead cell imaging, flow cytometry,
immunoblotting, enzyme-linked immunosorbent assays and fluorescence spectroscopy. Overall, we expect to
develop a hydrogel technology of broad applicability to reduce inflammation in the absence of drug loading by
targeting the inflammasome, which is implicated in many inflammatory diseases.

Public health relevance
PROJECT NARRATIVE Inflammasomes are large protein complexes that trigger inflammatory responses in the presence of injury or infection. Inflammasome dysfunction leads to chronic inflammation; an underlying cause of several human diseases such as atherosclerosis, rheumatoid arthritis, diabetes, cancer, and neurological disorders. This project is relevant to public health because it proposes to broadly reduce inflammation by capturing extracellular inflammasomes using a hydrogel technology that does not require drug loading and is tunable to potentially create implantable, injectable, and sprayable hydrogels for expanded biomedical applications.